Mechanisms and consequences of impaired glutathione homeostasis in the aging lens

Abstract
The integrity of the lipid and cholesterol-enriched lens membrane is vital to lens homeostasis, stiffness, and
transparency, serving as an impermeable barrier to cations and scaffold for major lens membrane proteins, such
as aquaporin 0 (AQP0) and ion pump. Aging is a primary risk factor for cataractogenesis and presbyopia, and it
drives a significant degree of lens membrane lipids compositional changes, such as the decline of unsaturated
glycerophospholipids and the steady increase of more saturated sphingomyelin lipids. The steep decline of highly
unsaturated glycerophospholipids in the lens is believed to result from selective lipid peroxidation, closely
associated with lens stiffness and membrane disintegration. Accumulated lens membrane disintegration can
cause a cataract, and increased lens stiffness is a primary cause of presbyopia. Despite overwhelming
suggestions, the direct link between lipid peroxidation and lens membrane transformation, and its impact on lens
stiffness and opacity, has yet to be established. Our studies have suggested that GPX4/GSH plays a crucial role
in maintaining lens plasma membrane integrity and transparency, as well as protecting against lipid peroxidation-
mediated cell death, such as ferroptosis. In this application, we aim to address these questions using in vitro
lens epithelial cell culture and in vivo mouse models directly targeting GPX4. The outcome of this study will
provide valuable insights into the lens membrane biology of aging and age-related cataractogenesis and
presbyopia.

Public health relevance
PROJECT NARRATIVE As we get older, our lenses can become stiff and cloudy, which can lead to vision problems such as cataract and presbyopia (difficulty seeing things up close). This happens because of a buildup of damage caused by oxidation, which is a process that occurs naturally in the body. This study will look at the specific reasons why oxidation occurs and how it contributes to lens aging.